Antibacterial and Antithrombotic Catheter Lock Solutions Based on Controlled Release of Nitric Oxide

SUMMARY
Central venous catheters are an indispensable tool in modern clinical practice to provide venous access for
hemodialysis, chemotherapy, parenteral nutrition, and repeated blood sampling. However, they carry a high risk
of infection and thrombosis, leading to increased morbidity, mortality, and length of hospital stay. The frequent
use of antibiotics and anticoagulants to prevent and treat these complications causes bacterial resistance and
adverse side effects such as bleeding. Therefore, there is a pressing need for novel strategies to reduce
infectious and thrombotic complications associated with central venous catheters. This project aims to combat
these complications using catheter lock solutions that release nitric oxide (NO), a natural drug exerting both
bactericidal and antithrombogenic activities without engendering drug resistance and side effects. The lock
solution contains S-nitrosoglutathione as a natural and non-toxic NO donor. Precisely controlled release of NO
is achieved by our innovative formulations based on the formation of host-guest inclusion complexes with the
zwitterionic form of S-nitrosoglutathione and the creation of suspensions of S-nitrosoglutathione nanocrystals.
The duration of NO release is tunable from 1 day to over 1 month to meet the requirements of locking regimens
in different catheter applications. The flux of NO is controlled within the safe and effective range to inhibit bacteria
and thrombus growth without causing toxicity to tissue and blood. Due to the high diffusivity of NO through the
polymer walls of intravascular catheters, it is not only generated in the intraluminal space and distal catheter
opening, but also released from the exterior surface of the catheter and the hub. Compared to other lock solutions
using traditional antimicrobials or anticoagulants, the NO release solution is unique due to its full protection over
the entire catheter from both bacterial colonization and thrombus formation.
In Aim 1, we will design various S-nitrosoglutathione formulations to provide short-term, medium-term, and long-
term NO release from commercial central venous catheters made of silicone rubber or polyurethane. In Aim 2,
the in vitro antimicrobial activity of the NO release lock solution against planktonic and biofilm bacteria will be
tested using five prevalent bloodborne microbes including a multidrug-resistant strain. Potential lytic activity to
erythrocytes and toxicity to endothelial cells will be evaluated in vitro. In Aim 3, the antithrombotic efficacy of
short-term and medium-term NO release lock solutions will be assessed in 7-day pig experiments. The locking
protocols will simulate the locking frequencies in hemodialysis and chemotherapy. In Aim 4, a 4-week chronic
pig model will be used to compare solutions with 3 days, 1 week, and 4 weeks of NO release with taurolidine-
citrate-heparin lock solutions with regard to both infection and thrombosis. Success of this project would lead to
a new generation of inexpensive lock solutions that will dramatically reduce infectious and thrombotic risks of
central venous catheters.

Public health relevance
Narrative This project aims to develop catheter lock solutions containing a natural prodrug, S-nitrosoglutathione, to generate nitric oxide, a natural drug with potent antimicrobial and antithrombogenic properties. Nitric oxide releases from the catheter lumen as well as the exterior catheter surface, protecting the entire catheter from infectious and thrombotic complications. Our advanced formulations of S-nitrosoglutathione deliver safe and effective levels of nitric oxide to meet the locking needs of central venous catheters in applications such as hemodialysis and chemotherapy.